Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The CRISPR Vision Program is a truly team science unique effort to advance gene editing therapeutic
candidates for several retinal channelopathies towards the clinic. This proposal leverages synergy between
discoveries in engineering and biology and requires close collaborations and contacts between academic
labs, industry partners, regulatory professionals, manufacturing facilities, the National Institutes of Health
(NIH), and the U.S. Food and Drug Administration (FDA). This large effort therefore requires strong
administrative support from the Administrative (Admin) Core, whose overarching goal is to ensure efficiency,
teamwork, and synergy among the Projects and Cores by providing infrastructure spanning software,
meetings, finances, staffing, logistics, communications, and publications. All these activities are critical to an
innovative team science approach taken by the CRISPR Vision Program. The Admin Core builds on
organizational principles that have proven successful during Phase I of the SCGE and several extramural
projects since 2018. These principles include several supporting functions including communication, record
keeping, process reports, publications, infrastructure, working relationships with university admin, software
tools, and many more. In practice, four primary tasks will be executed. First, the Admin Core will assign and
manage personnel to ensure all Projects and Cores are appropriately staffed and form committees to oversee
all duties. The Admin Core will perform project management tasks based on the information they collect from
regular meetings, comparison of progress to the phase timelines, and other factors. Second, the Admin Core
will support communication and synergy among team members through organizing regular meetings,
adopting standard practices for data and protocol sharing, and providing software tools to assist with project
management and team communication. Third, the Admin Core will coordinate external communications of
research, datasets, protocols, and processes including information sharing with the NIH, the SCGE
Consortium Translational Coordination and Dissemination Center, and across other Centers, and
dissemination and publication of results and resources. Finally, the Admin Core will provide financial
management, interface with institutional administration, and ensure the cost-effective use of resources across
the Projects and Cores. Overall, the Admin Core will help integrate the Projects so that true Team Science
can be achieved within each Project and also between Projects. The points of synergy are expected to provide
a rapid translation of promising genome editing technology into the clinic. The Admin Core will be led by Dr.
Krishanu Saha, who brings leadership experience with many large team science initiatives including the
Phase I of the SCGE. The Core will benefit from a Program Manager who will execute the tasks above with
Dr. Saha and an experienced set of grants administrators at the University of Wisconsin-Madison.